Increasing Reach of Effective Virtual Specialty Care for Adults with Diabetes Through Tailored Modalities

PROJECT ABSTRACT
Use of telemedicine to deliver specialty care to adults with type 2 diabetes (T2D) has increased rapidly in the
last 3 years and persists as a means to enhance access to care for many patients who face barriers to in-
person care, such as those in rural areas, or with limited mobility or transportation. However, evidence
suggests that telemedicine is less effective than in-person care for patients with complex T2D, including those
who use multiple daily injections of insulin and have multiple comorbid conditions. Endocrinologists report that
components of high-quality care, including diabetes self-management education and home blood glucose data
sharing, are more difficult to deliver via telemedicine. Barriers to delivery of high-quality care can have greater
impact on adults with complex T2D, whose disease is already more difficult to manage and who are at higher
risk of diabetes-related complications and mortality. Therefore, current gaps in diabetes care quality between
in-person and telemedicine care for adults with complex T2D must be characterized and addressed in order
for expanded access to care via telemedicine to translate into improved diabetes outcomes for all patients,
especially those at highest risk. This K23 award will support the health services research career development
of endocrinologist Margaret Zupa, MD MS. Dr. Zupa will use data from a large integrated health system to
inform design of a pragmatic intervention to deliver high-quality care to adults with complex T2D via
telemedicine through the following specific aims: Aim 1) Characterize gaps in delivery of high-quality care
elements via telemedicine for adults with complex T2D. Aim 2) Leverage patient and provider perspectives to
develop an intervention to deliver high-quality diabetes telemedicine care for adults with complex T2D. Aim 3)
Determine feasibility and preliminary outcomes of a pragmatic intervention to provide high-quality diabetes
telemedicine care for adults with complex T2D. With the knowledge gained in these aims, Dr. Zupa will
develop an approach to improve care quality and clinical outcomes for adults with T2D who are at high risk of
adverse diabetes outcomes and rely on telemedicine to access care.
Dr. Zupa has developed a thorough training and mentoring plan which aligns with the above research. She will
build skills in advanced quantitative modeling of care pathways and outcomes, pragmatic clinical trial design,
and application of implementation science mixed methods to healthcare delivery. An experienced,
multidisciplinary team of mentors with a strong track record of impactful diabetes and virtual care research is
committed to supporting Dr. Zupa in achieving these career development and research goals and in
progressing to independence as a health services researcher. This mentored research and training will lead to
the development of a future hybrid effectiveness-implementation randomized trial to evaluate the impact of this
intervention on clinical, patient-centered, and quality outcomes.

Public health relevance
PROJECT NARRATIVE Nearly 20% of the more than 30 million Americans with type 2 diabetes face geographic or transportation barriers to diabetes specialty care. Telemedicine has the potential to help more patients access this care, but evidence suggests telemedicine is less effective for adults with type 2 diabetes which is complex, including those who use multiple daily injections of insulin and have multiple comorbid conditions. The objective of this project is to develop an intervention to deliver high-quality virtual diabetes specialty care to adults with complex type 2 diabetes, thereby improving effectiveness of care for patients who rely on telemedicine.